Characterizing the Genetics of FASD in Complementary Mouse and Fish Models

Project Summary/Abstract
Alcohol (ethanol) exposure during pregnancy is the leading environmental cause of birth defects and central
nervous system dysfunction. While the effects of ethanol on the brain and face have been explored quite
extensively, there is considerable variation in the consequences of developmental ethanol exposure. Some of
this variation is due to differences in timing and amount of exposure or nutritional factors. However, even when
controlling for these factors, it is still clear that not everyone exposed to ethanol during development is affected
equally and it has become increasingly clear that genetic factors play a very significant role in fetal alcohol
spectrum disorders (FASD). Historically, elucidating these genetic factors that mediate risk or resilience has
been relatively slow and characterized by human association studies or quantitative trait loci mapping in animal
models. More recently, we have applied next generation sequencing technologies and forward genetic screens
to more rapidly identify genes and pathways that alter susceptibility to prenatal ethanol exposure. These
studies have taken advantage of varied mouse strains with differential alcohol susceptibility, numerous
transgenic mouse lines, and high throughput zebrafish genetic analyses and CRISPR/Cas9 gene editing
techniques. In this current proposal, we will further these approaches with the combination of the powerful
genomic analyses capabilities of the Collaborative Cross mouse genetics tools. In Aim 1, we will explore
mechanisms underlying ethanol sensitivity using complementary mouse and fish transgenic lines, while
identifying further candidate genes via comparisons of the highly ethanol susceptible mouse strain, C57BL/6J
vs. the highly ethanol resistant strain 129S1/Svlmj. This comparison will be aided by embryonic transcriptomic
(RNA-Seq) analyses, selective crossbreeding to induce susceptibility in a resistant line (129) with extensive
genome sequencing analyses. Aim 2 will significantly expand our genomic analyses by examining CC founder
strains for their susceptibility to ethanol followed by transcriptomic profiling of susceptible and resistant strains.
Conserved candidate genes and pathways will be further tested and characterized in our high throughput
zebrafish phenotyping analyses. Aim 3 will take a complementary bioinformatic approach by identifying
chemical modifiers of gene-ethanol interactions in a high throughput zebrafish screen with further confirmation
in our mouse model of FASD. This proposal brings together experts on mouse and fish genetics, embryology
and alcohol teratology. Together, these experiments will greatly enhance our understanding of the genetic
etiology of ethanol-induced brain and craniofacial malformations during early embryonic development, as well
as aiding in the identification of the pathogenic mechanisms involved in FASD.

Public health relevance
Project Narrative The goal of this work is to increase our understanding of the genetic predispositions underlying FASD and to uncover novel pathogenic mechanisms in order to aid in prevention and intervention efforts. We will use genomic, transcriptomic, and chemical interactions in zebrafish and mice to discover novel candidate genes that modify susceptibility to early gestational ethanol exposure. Subsequent experiments will use gene editing in zebrafish and mice to further confirm candidate genes that may interact with ethanol.